EFFECT OF INTRAVENOUSLY ADMINISTERED EPINEPHRINE ON CARDIAC REPOLARIZATION

The effect of increasing doses of epinephrine administered via continuous intravenous infusion on the surface ECG, serum kt, pulse, blood pressure, and circulating catecholamines will be determined.